Restoring awareness of hypoglycemia in type 1 diabetes

PROJECT SUMMARY / ABSTRACT
This application “Restoring awareness of hypoglycemia in type 1 diabetes” proposes to elucidate the
heterogeneity of impaired awareness of hypoglycemia (IAH) in type 1 diabetes through completion of a 24-month
Sequential Multiple Assignment Randomized Trial (SMART) designed to better inform our understanding of the
clinical and physiologic factors which contribute to restoration of counterregulatory defenses against
hypoglycemia in response to educational, technologic, and pharmacologic interventions. Given the persistent
barrier of hypoglycemia to the realization of achieving adequate glycemic control for most individuals with type
1 diabetes, there is a critical need to further understand the mechanisms contributing to hypoglycemia in type 1
diabetes in order to advance treatment approaches that may realize the benefits of near-normal glycemic control
without the accompanying risk for severe hypoglycemia. The present proposal aims 1) to determine whether
counterregulatory responses to a hyperinsulinemic hypoglycemic clamp can be restored in individuals with long
standing type 1 diabetes and IAH using an adaptive randomized clinical trial design implementing state-of-the-
art interventions including hypoglycemia avoidance education (standard-of-care; SOC), automated insulin
delivery with hybrid closed loop technology (HCL), and novel mini-dose glucagon (MDG) pharmacology; 2) to
determine the physiological factors associated with improved counterregulatory responses following intervention,
including but not limited to age, diabetes duration, and continuous glucose monitoring (CGM) metrics; and 3) to
validate a HypoA-Q short form questionnaire as a self-report measure for identifying IAH with measurement of
counterregulatory responses derived from the hypoglycemic clamp. The proposed SMART study design will
allow for rigorously determining both the degree of hypoglycemia avoidance necessary for improvement of
counterregulatory epinephrine and autonomic symptom responses to insulin-induced hypoglycemia, as well as
the additional factors such as age, diabetes duration, other CGM metrics, and validated IAH self-report that may
predict individual responsiveness to SOC, HCL, and MDG interventions.

Public health relevance
PROJECT NARRATIVE Hypoglycemia remains a major barrier to the achievement of adequate glycemic control for most individuals with type 1 diabetes. Moreover, a substantial portion of adults with type 1 diabetes experience life-threatening episodes of severe hypoglycemia, and those with long standing disease complicated by impaired awareness of hypoglycemia (IAH) share the greatest burden of problematic hypoglycemia and its related morbidity and mortality. The present proposal aims to determine whether counterregulatory responses to hypoglycemia can be restored in individuals with long standing type 1 diabetes and IAH using state-of-the-art interventions implemented by an adaptive randomized clinical trial design with outcomes related to measures of physiologic defense mechanisms against the development of low blood glucose, glycemic control derived from continuous glucose monitoring, and participant reported assessment of hypoglycemia problems.